Research training in Pediatric Endocrinology

ABSTRACT:
This application seeks support for a NIH Ruth L. Kirschstein National Research Service Award
(NRSA) Institutional T32 in Pediatric Endocrinology at the UPMC Children’s Hospital of Pittsburgh
(CHP), University of Pittsburgh. Pediatric endocrine disorders such as type 1 diabetes, childhood
obesity and type 2 diabetes have major consequences in adulthood including cardiovascular
disease, blindness, and kidney failure. Despite the urgent need for research to better understand
these pediatric disorders and mitigate long-term health effects, the number of Pediatrics-focused
research training programs to provide the training essential for launching a successful research
career is limited. Indeed, there are only seven active T32 training grants in Pediatric
Endocrinology in the U.S. We seek support through this grant to 1) expand outstanding training
opportunities in pediatric endocrinology; 2) achieve national priorities to cultivate the future
leaders of clinical, preclinical, and translational research; and 3) prepare a cadre of skilled
pediatric endocrinologists to address the critical shortage of physician-scientist investigators
dedicated to research focused on diabetes, obesity, and metabolism. The T32 program will
include training in endocrine physiology, molecular genetics, molecular and cellular biology,
biostatistics, bioinformatics, epidemiology, metabolomics, microbiome homeostasis, ethics of
human research, clinical trials, grant writing, and career guidance. To achieve these goals, we
have recruited faculty mentors who are academically productive and dedicated to the training of
scientists and physician-scientists. Research focus of this training grant includes diabetes,
obesity, metabolic disorders, beta cell and adipose tissue biology for 22 out of 24 of the mentors
(92% of the mentor pool), one of the biggest problems facing us at the present. We will recruit a
cohort of highly qualified trainees. Of the potential applicant pool, 13/14 (93%) of our trainees are
engaged in diabetes-related research, providing a rich opportunity. Our T32 program will provide
a nurturing environment, mentorship and infrastructural support for physician-scientists and Ph.D.
scholars to acquire the skills necessary to design, implement and interpret clinical trials and
research projects in pediatric endocrinology and diabetes.

Public health relevance
Project Narrative Pediatric Endocrinology is one of the smallest pediatric subspecialties. Obesity and diabetes (both type 1 and type 2) in youth are on the rise with major current and future impact on overall health. Very few pediatric endocrinologists have had adequate training and mentorship in research, and thus lack the skills to perform cutting-edge research in pediatric endocrine diseases. This training grant will educate a new generation of pediatric endocrinologists and Ph.D. scientists, who can play a role as leaders and researchers in pediatric endocrinology and diabetes.